Using functional magnetic resonance imaging to understand how positive and negative TDM experiences relate to mental and behavioral health

PROJECT SUMMARY – PROJECT 2
Social connectedness and inclusion are essential for well-being and health, particularly during adolescence, a
period characterized by an increased salience placed on peer relationships and experiences. Technology and
digital media (TDM), particularly social media, has the affordance of connecting with peers. In fact, TDM has
become an increasingly important form of communication for adolescents, 71% of adolescents report using more
than one social media site and 92% of adolescents between the ages of 13-17 years old report going online
daily. Reviews on TDM use, however, suggest that there is not consensus on the impact of TDM and social
media use on well-being and health behaviors among adolescents, finding positive, negative, and null results.
They highlight that little evidence exists that examines potential moderating factors between TDM use and well-
being and health outcomes, which limits our understanding of what influences outcomes of interest. Thus, there
is an urgent need to fill this gap. Effects associated with TDM use may depend on specific ways that adolescents
use TDM. For example, if high levels of exposure to certain kinds of TDM, such as social media, sensitize
adolescents to other people’s opinions, they may be more reactive to negative experiences such as social
exclusion, but may benefit more from experiences of social inclusion. This sensitivity may help explain the mixed
findings within the literature. The current study proposes to test this idea by measuring adolescent’s exposure to
social media (drawing data from Projects 1 and 3) that have the affordances of social connectedness (i.e., likes,
comments, number of friends or followers). Then we will relate these experiences longitudinally to their reactivity
to experiences of social inclusion and exclusion to predict health and risk behaviors as well as well-being
(drawing data from Projects 1 and 3) and examine how changes in functional reactivity across the social transition
period from middle to high school, a period associated with changes in social ties, risk-taking, and challenges to
well-being, may influence these relationships. This data will not only examine deficits associated with social
media use that lead to poorer well-being and unhealthy behaviors, but will also examine the strengths of social
media use and how they relate to better well-being and healthy behaviors. Further, if adolescents are sensitized
to social cues, the data can help identify ways to help steer adolescents towards social media engagement that
leads to greater well-being and healthier behaviors. This project aligns with the current RFA as it tests how TDM
usage affects health behavior. This project specifically aligns with two areas of interest for this RFA: 1)
interdisciplinary studies of TDM usage across adolescence employing multi-level assessments of
neurodevelopment to examine interrelated developmental changes in brain function and complex behavior, and
2) real-time measures of TDM exposure and usage and how this usage regulates adolescents’ behavior.

Public health relevance
PROJECT NARRATIVE – PROJECT 2 Not applicable. Per the Funding Opportunity Announcement PA-HD-22-009, the Project Narrative is not required for the Project or Core components.